Developmental Funds Core

DEVELOPMENTAL FUNDS: ABSTRACT
The University of Kansas Cancer Center (KUCC) requests Cancer Center Support Grant (CCSG)
Developmental Funds to support pilot research projects, supplement new faculty recruitment packages, and
support Clinical and Special Populations Staff Investigators to promote translational and clinical science
research activities and help extend those research activities to underrepresented populations. Funding pilot
projects, recruiting new faculty, and supporting Staff Investigators will collectively enrich research endeavors
towards strategic priorities, enhance the ability of KUCC to serve the Cancer Center’s catchment area, and
importantly help mitigate the impact of cancer in our region as well as nationally. KUCC leadership believes
that activities supported by CCSG Developmental Funds will enable KUCC to provide a rich environment to
develop paradigm-changing therapeutics and interventions, and thereby enable the funding of multi- and
transdisciplinary team-based grants. These funds will allow us to focus the power of precision medicine, basic
science inquiry, drug discovery and development, and behavioral interventions to decrease cancer incidence,
morbidity, and mortality. Furthermore, Developmental Funds will help KUCC promote a Cancer Center culture
that supports our highest priority of leveraging the collective state-of-the-art basic, clinical, translational and
population research programs to understand cancer at a fundamental level and catalyze a comprehensive,
multidisciplinary approach to improve patient outcomes. KUCC has demonstrated a successful track record in
its investment of CCSG Developmental Funds and other KUCC-directed funding mechanisms since receiving
NCI designation in 2012 and will continue to grow a strong return on investment from these funds.